Improving phage-based medicine with immunoengineering

PROJECT SUMMARY/ABSTRACT
A resurgence of research interest in bacteriophages, viruses that infect bacteria, is driving the development of
engineered phages for biomedical applications, including antimicrobial therapy and phage-based vaccination.
As antimicrobial agents, phages have significant advantages over conventional antibiotics: they are well-
tolerated, pathogen-specific, and replicate at the site of infection. Phages are also promising as vaccine
platforms because they can be precisely engineered to deliver multiple foreign antigens. However, phages are
immunogenic and both applications are susceptible to interfering immune responses. Antimicrobial phages, for
example, can elicit neutralizing antibodies that prevent infection of the bacterial target. This immunogenic
nature is advantageous for vaccine development, since the phage acts as its own adjuvant, but it comes at a
price: off-target responses to immunodominant phage antigens can distract from intended protective responses
to foreign antigens. Unfortunately, data on phage immunology are limited, confounding routine biomedical
applications of phage. This proposal outlines basic experiments to elucidate the basis of phage
immunogenicity and evaluate methods of modulating it.
Aim 1 will develop a structural map of antibody binding to three therapeutic mycobacteriophages. Structure-
guided engineering and directed evolution will be used to generate mutant phages that escape antibody
binding. The ability of these mutants to evade established immune responses to their wild-type counterparts in
vivo will be evaluated in a mouse model. In Aim 2 the same phages will be used as platforms for a therapeutic
bacterial vaccine. Leveraging both phage display and phage DNA vector technologies, the vaccine candidates
will defend and protect against bacteria with three mechanisms: 1) phage infection and killing, 2) generation of
bacterium-binding antibodies, and 3) activation of helper and cytotoxic T cells. Aim 3 will evaluate a method to
suppress interfering immune responses: co-administration of phage with rapamycin-loaded nanoparticles. This
will down-regulate phage-specific helper T cells and upregulate regulatory T cells, training the immune system
to recognize phage as ‘self’. These Aims will expand our understanding of phage immunogenicity and assess
the potential to improve phage-based medicine with principles from immunoengineering. Furthermore, Aim 1 is
a training vehicle for the candidate, who has developed immunology experience in the lab but requires
mentored training and formal education to establish independence in this field. Aim 1 also provides additional
mentored training in structural biology, specifically asymmetric reconstructions of phage-antibody complexes.
With the planned scientific training, practice in publishing and grant writing, and the support of her mentors
throughout an academic job search, the candidate is expected to establish and sustain an independent
research career focused on immunoengineering phage to improve their biomedical applications.

Public health relevance
PROJECT NARRATIVE Bacteriophages, viruses that infect bacteria, can defend against emerging pathogens when deployed as targeted antimicrobials or vaccine platforms. However, the human immune response to bacteriophage administration can interfere with efficacy. The proposed research will improve our understanding of bacteriophage immunogenicity and establish novel methods of modulating it to improve phages for biomedical applications.